Nanoparticulate Coatings Enhance Ion Detection

DESCRIPTION (provided by applicant): A new thin film approach to increasing the gain and sensitivity of current and future fast particle detectors is hypothesized. An increased ion induced secondary electron yield at the first surface of the detector while retaining high timing accuracy will make such detectors suitable replacement for MCP detectors in biological applications such as electron or ion microscopies and time of flight mass spectrometers. Moreover, the detector may be sensitive to the energy or momentum of the incoming ion. Such information could simplify MALDI or electrospray MS spectra containing highly charged molecular ions.

Public health relevance
PUBLIC HEALTH RELEVANCE: A new type of ion detector will enhance secondary electron gains compared to standard multi-channelplate detectors. Direct replacement sale of detectors or sale of ion detectors and electronics are both commercial options. This will greatly improve mass spectra of systems in use.